High-Resolution Inference for Correlates of Vaccine Protection

Project Summary/Abstract Statisticians play in a key role in quantifying the uncertainty in ﬁndings from clinical trials, observational studies, and other data sources, thereby enabling rational decision making based on the ﬁndings and protecting against the human tendency to see signal in noise. Ideally the validity of the uncertainty quantiﬁcation, also known as statistical inference, will be agnostic in the sense that it avoids reliance on implausible assumptions, thereby improving the interpretability and credibility of the resulting ﬁnd- ings. There has been much progress over the last several decades in obtaining agnostic inference of population-level quantities, such as (i) the percent reduction in infection in vaccinees compared to place- bos or (ii) the average treatment effect if the entire population receives treatment versus control. There has been relatively little progress, on the other hand, in obtaining agnostic inference of higher-resolution quantities, such as (i) the percent reduction in the probability of infection in vaccinees compared to place- bos, conditional on a continuous measure of immune response or (ii) the average treatment effect for an individual based on a high-dimensional set of observed covariates. These high-resolution quantities are function-valued in the sense that they are respectively deﬁned as functions of immune response and subject covariates. While inference for high-resolution quantities can be obtained when one is willing to commit to strong assumptions on the observed data distribution, these methods are plagued by the same deﬁciencies of poor interpretability and damaged credibility faced by non-agnostic inferential procedures for population-valued quantities. In contrast to the limited progress on obtaining inference for more reﬁned quantities, there has been considerable progress towards obtaining inference-free point estimates of (i) the percent reduction in infection probability conditional on immune response markers and (ii) the average treatment effect conditional on covariates. This progress has come from several ﬁelds, including statistics, machine learning, and computer science. This proposal outlines a uniﬁed methodology for obtaining inference for high-resolution quantities, where the proposal draws inspiration from a framework developed for population-level quantities, namely targeted minimum loss-based estimation, but features highly original developments that enable inference for higher-resolution, function-valued quantities. This work has the potential to make a major impact on the identiﬁcation of individual-level variables that correlate with vaccine efﬁcacy, including in identifying individuals who will be harmed by the only licensed dengue vaccine and in identify vaccine-induced immune responses that correlate with prevention in two ongoing HIV vaccine efﬁcacy trials. The potential for broad impacts to other areas of biomedical research, including precision medicine, are also described.

Public health relevance
Project Narrative The statistics and machine learning communities have made remarkable progress in developing highly ﬂexible data mining procedures that, for example, enable (i) the identiﬁcation of potentially protective vaccine-induced immune responses and (ii) the prediction of the optimal treatment for a given individual. Despite this progress, there has been little progress in quantifying the uncertainty in the output of these ﬂexible procedures without making implausible assumptions on the mechanism that generated the data, where the likely failure of these assumptions renders it difﬁcult to make (i) informed vaccine development decisions based on the identiﬁed immune response or (ii) treatment decisions based on the predicted optimal treatment. The proposed work develops a uniﬁed methodology for quantifying the uncertainty in estimates obtained using these data mining techniques, thereby enabling informed decision making.